Defining the role of KEAP/NRF2 signaling dysregulation and sensory nerve reprograming during acquisition of cisplatin resistance and metastasis in HNSCC

Project 2 SUMMARY
Cisplatin (CDDP) is frontline therapy for both Human Papilloma Virus (HPV) positive and negative head
and neck squamous cell carcinomas (HNSCC). Unfortunately, there are no reproducible predictors of CDDP
HNSCC response and patients develop acquired resistance and even distant metastasis following a course of
this often toxic chemotherapy. To better understand and tackle the clinical problem of CDDP treatment failure,
we developed multiple cell line models of acquired CDDP resistance in the laboratory using established HNSCC
tumor lines with different genomic backgrounds and TP53 mutational and functional status. Surprisingly, nearly
every CDDP resistant clone developed from these various genomic driver backgrounds had hyperactivation of
the Nrf2 pathway either due to de novo somatic mutations in, or decreased RNA expression of, KEAP1 (negative
regulator of Nrf2). Nrf2 activation has been linked to poor prognosis, lack of response to immune therapy,
metastasis, and chemotherapy resistance. We demonstrated that Nrf2 hyperactivation was necessary to
maintain acquired resistance, raising the possibility that the pathway could be clinically targeted to reverse or
prevent acquired CDDP resistance in HNSCC. By targeting glutaminase 1 (GLS) with a novel drug, pools of
glutathione needed for Nrf2 activity are depleted leading to a reversal of CDDP resistance.
In parallel, we showed that paracrine signaling between sensory neurons that become reprogramed in
the tumor microenvironment can foster CDDP resistance and that it may be possible to pharmacologically inhibit
this signaling axis to boost CDDP sensitivity and tumor progression. Furthermore, data from our preclinical model
suggest that Nrf2 activation accompanying CDDP resistance may also lead to more aggressive disease by
increasing the rate of distant metastasis. While Nrf2 hyperactivation is likely a permissive and required step to
acquired CDDP resistance, there may also be Nrf2 independent pathways contributing to resistance. Our central
hypothesis is that Nrf2 hyperactivation either through somatic mutation for transcriptional control is a common
and targetable event in development of acquired CDDP resistance across a range of genomic backgrounds. To
bridge knowledge gaps in the pervasiveness of the Nrf2 pathway in development of CDDP resistance and tumor
progression and ways to overcome treatment failure we propose the following Aims: 1) Define the contribution
of Nrf2-dependent and-independent pathways to acquired CDDP resistance in HNSCC; 2) Delineate the
functional and mechanistic interactions between acquired CDDP resistance, Nrf2 activation, neuronal
reprograming in the tumor microenvironment, and DM; 3) Determine whether acquired CDDP resistance and
tumor progression can be overcome by drugs targeting metabolism or stabilizing p53. Accomplishment of these
Aims should yield translatable findings that will improve the treatment of patients with HNSCC and the related
upper-aerodigestive tract cancers of the lung and esophagus and therefore have a major impact on cancer
worldwide.